Neuroprotective Immunity and HIV Dementia

Abstract
This competitive renewal for 5 R01 NS034239 now in its 27th year provides a research plan reflecting the National
Institutes of Health strategic plan for HIV and HIV-related research. The plan lists neurologic complications as a
primary study need. The current study seeks to investigate the interplay between aging, HIV-1 infection, and
neurodegenerative diseases. The preliminary data now offered targets a significant need in biomedical research
for neuroHIV. That need is the discovery and characterization of a viable animal models that would mimic the
neuropathobiology of HIV-1 infection in the setting of Alzheimer’s disease (AD). It was previously not possible to
study a dynamic interplay between viral infection of CD4+ T cell subsets, immunity, antiretroviral therapy (ART),
and AD. We solved that problem as during the last grant cycle we created the needed model. Herein, we provide
extensive data of its utility, have outlined viable experimental approaches, and affirm its significance to provide
significant new insights into better understanding disease mechanisms and potential therapeutics that can be
realized during the 28th to the 33rd year of the project. The proposed work rests on a sound research foundation
by building on fundamental research findings made during the prior granting cycle. During that time we showed
that amyloid β (Aβ)-specific helper T cell type-1 (Th1) and -17 (Th17) effector T cell (Teff) clones propel
neurotoxic innate neuroinflammatory responses, proteinopathy, and neuronal dysfunction that were associated
with cognitive impairment in amyloid precursor protein transgenic mice. Moreover, through parallel studies, we
demonstrated that regulatory T cells (Treg) attenuate neuroinflammation and AD neuropathology, then restore
cognitive function. With our novel AD humanized mice in hand, we now show that during HIV-1 infection we not
simply see increases in neuroinflammation but that viral immune response can facilitates proteinopathy. We are
now able to conduct studies of HIV-1 compartmentalization, virus-amyloid adaptive and innate immunity
alterations, and consequences of immune-pathogenic and regulatory events. These can serve both to accelerate
or ameliorate AD processes. The aims of the proposal will be to fully characterize the model at the cell, immune,
tissue, and disease level by studies of innate macrophage-microglia and adaptive CD4+ Teffs pro-inflammatory
factors known to affect the brain’s microenvironment. The second component will assess immune transformation
by a spectrum of therapeutic agents that include antiretroviral therapy. We will now directly interrogate how T
cell immunity drives the tempo of both HIV/AIDS in the setting of neurodegenerative disease. Finally, Tregs that
are engineered to recognize Aβ by a transgenic T cell receptor (TCR) or a chimeric antigen receptor (CAR), will
be employed as “future” therapeutic strategies to restore brain homeostasis, reduce plaque burden, and affect
neuroprotective outcomes. Overall, we are, now in a position to investigate chronic HIV-1 infection in the setting
of progressive AD and can study its relationship to immunity and ART with this new small animal models in hand.

Public health relevance
Relevance We propose to study the novel humanized mouse model of Alzheimer’s disease we created which allows, for the first time, studies of disease progression in the face of HIV- 1 infection and antiretroviral therapy. The model now enables studies of immune cell subsets and novel therapies that enables the simultaneous suppression of viral growth while clearing plaques and tangles that affect AD progression. This research builds on groundbreaking work that served to define the mechanism(s) of viral persistence in the central nervous system, deliver medicines to sites of viral growth, and most importantly determine how specific CD4+ T cell subsets can affect the tempo of disease and secondly provide immune based disease to combat progressive viral infections.